Biostatistics

The Biostatistics Core (Biostats) is a centralized and dedicated resource structured to meet biostatistical needs
of the Holden Comprehensive Cancer Center (HCCC). Quality biostatistical support promotes good study
design, efficient use of resources, and effective analysis of data. Biostats provides such support in close
collaborations with HCCC members, other shared research resources, and administration to advance the
research and education missions of the HCCC. The comprehensive nature of Biostats assures cost-effective
access to biostatistical support that includes study design and development; protocol review and study
monitoring; research data management; statistical analysis and programming; analysis reporting and
publication; methodological development; and education, training, and professional development. The primary
resources of Biostats are the expertise and time of its biostatistician personnel. In order to meet HCCC
biostatistical needs, Biostats includes personnel who have a wide range of expertise, including experimental
design, clinical trials, statistical computing, spatially and temporally correlated data analysis, genetic and
genomic data analysis, and Bayesian statistics. Personnel are active participants in multiple aspects of the
HCCC. They serve on the HCCC Protocol Review and Monitoring Committee and the Data Safety and
Monitoring Committee. Collaborations involve all research programs and close interactions with the Population
Research Core, Biospecimen Procurement and Molecular Epidemiologic Resource, as well as the Clinical
Research Services. Additionally, Biostats provided educational training and professional development. In
summary, Biostats is a highly collaborative, productive, and integrated resource that is vital for the HCCC.

Public health relevance
PROJECT NARRATIVE Not applicable